Regulation of Translation by O-GlcNAc - Resubmission 03-05-2020

The cycling of N-acetylglucosamine on Ser(Thr) residues (O-GlcNAcylation; OGN) on nuclear,
cytoplasmic and mitochondrial proteins serves as a nutrient sensor to regulate signaling, transcription, and
cellular physiology. Abnormal OGN underlies the etiology of diabetes, cancer and Alzheimer’s disease. OGN
regulates nearly every aspect of transcription, including RNA polymerase II, histones, DNA
methyltransferases, and nearly all transcription factors. Recent findings by us and others indicate that O-
GlcNAcylation also regulates protein translation and mRNA utilization, but much less is known.
Understanding how nutrients and stress regulate protein translation via OGN is not only critical to our basic
understanding of one of the cell’s most vital processes, but also is key to understanding mechanisms
underlying chronic diseases of aging, such as diabetes, cancer and neurodegeneration.
We hypothesize that O-GlcNAc cycling on proteins in the translational machinery regulates proteostasis
by mediating communication between the proteasome and ribosomal machinery, and that nutrients regulate
translation rates and mRNA selection by dynamic O-GlcNAc cycling on many ribosome-associated proteins.
We propose three specific aims to advance our understanding of OGN’s roles in nutrient regulation of
translation: Aim 1 will use state-of-the-art mass spectrometric methods to identify both nascent and mature
ribosome associated proteins and translation factors that are modified by OGN, and we will specifically
focus on those that appear to be involved in ribosome:proteasome communication. We will then determine
the functions of OGN at the site level on selected OGN translation proteins. Aim 2 will elucidate how high
glucose alters the OGN of the translation machinery. Using both live HEK293 cells and a rabbit reticulocyte
translation system, we will determine if OGN plays a role in mRNA selection by performing RNA seq analyses
of polysome preparations. Aim 3 will determine the mechanisms by which the O-GlcNAc transferase (OGT)
and O-GlcNAcase (OGA) are rapidly targeted to ribosomes in response to proteasome inhibition.
These studies are not only elucidating molecular mechanisms of how nutrients regulate protein synthesis,
but they also are key to revealing how hyperglycemia, as occurs in diabetes, abnormally alters protein
expression in many tissues. Molecular mechanisms revealed in these studies will likely lead to totally novel
targets for the treatment of chronic diseases of aging, particularly diabetes.

Public health relevance
Project Narrative Decades of work have shown that a cycling sugar modification of proteins in the nucleus and cytoplasm of cells is a major mechanism by which what we eat regulates our cellular physiology. In fact, dysregulation of this sugar cycling contributes to major diseases of aging, such as diabetes, cancer and Alzheimer's disease. This project will investigate how this sugar modification regulates gene expression at the level of protein synthesis from messenger RNA.